Mitochondrial metabolism as a therapeutic target in pulmonary fibrosis

Project Summary/Abstract
Pulmonary fibrosis (PF) describes a group of disorders in which the alveolar space is progressively replaced by
fibrotic tissue which eventually leads to death from respiratory failure. Available therapies modestly slow disease
progression but are not curative, difficult to tolerate and most patients die unless they receive a lung transplant.
The prevalence of PF has tripled in the US Veterans Population between 2010 and 2019 and likely to continue
increasing in light of the COVID-19 pandemic. We were the first to show that some patients with severe COVID-
19 develop severe lung fibrosis that is indistinguishable from IPF even at the level of the single cell
transcriptome. These findings prompted us to perform the first of many lung transplants for patients with severe
COVID-19 in the US. Even more concerning, however, is the prevalence of respiratory symptoms in more than
30% of patients with post-acute sequelae of COVID-19 some of whom have PF. Thus, if even a small fraction
of the 66 million US survivors of COVID-19 to date develop fibrotic lung disease, the public health impact will be
enormous. Our laboratory has made important contributions to a model that hypothesizes that lung fibrosis
begins with damage to the alveolar epithelium which leads to the recruitment circulating monocytes to the
alveolar space where they differentiate into profibrotic alveolar macrophages to create a temporary seal over the
injured alveolar epithelium and in direct contact with alveolar fibroblasts. Trophic factors for fibroblasts are
released from alveolar macrophages and fibroblasts secrete G-CSF in response, which is necessary to sustain
alveolar macrophages and creates a profibrotic circuit that persists until the epithelial barrier is restored.
Metformin is an oral drug used for Type 2 diabetes that also ameliorates fibrosis in animal models but has not
been associated with improved outcomes in PF patients. Our preliminary data suggest these disparate findings
might reflect the pharmacokinetics of the drug—high levels of drug in the lung are only achieved with
intraperitoneal but not gut administration. Thus, while metformin may not be useful as a therapy for lung fibrosis,
small molecules that mimic its mechanism of action might be. However, this requires a mechanistic
understanding of metformin’s efficacy in lung fibrosis which is currently lacking. Metformin is concentrated in
mitochondria where it functions to inhibit Complex I of the mitochondrial electron transport chain. We have
identified a yeast protein, NDI1, that restores mitochondrial electron transport in the absence of complex I activity
and is insensitive to metformin. Using this construct, we have shown that many of metformin’s biologic effects
are attributable to its ability to inhibit complex I. We have also generated preliminary data suggesting a direct
activator of AMPK, an indirect target of metformin, prevents fibrosis after the intratracheal administration of
bleomycin. These data support our overarching hypothesis that modulation of mitochondrial metabolism is
necessary for the development of lung fibrosis, offering a novel therapeutic opportunity. We propose using novel
genetic tools to determine whether and how mitochondrial electron transport can be targeted for therapy to
ameliorate fibrosis in two interrelated Specific Aims. In the first aim we will determine whether metformin inhibits
complex I of the mitochondrial electron transport chain in the alveolar epithelium to activate AMPK and attenuate
lung fibrosis. In the second aim we will determine whether metformin inhibits complex I of the mitochondrial
electron transport chain and activates AMPK to prevent the recruitment or differentiation of profibrotic MoAM.
Our studies are founded on unbiased, rigorous and reproducible data from patients with PF and murine models
of lung fibrosis and will have immediate implications for therapy. We will credential a widely used metabolic
therapy with an acceptable risk profile, metformin, and determine its mechanism of action during lung fibrosis
which could be leveraged to identify drugs/formulations with more favorable pharmacokinetics in humans.

Public health relevance
Project Narrative Idiopathic pulmonary fibrosis (IPF) occurs when lungs heal abnormally after an injury and develop scarring. It is a devastating disease with treatments that are not very effective and cause intolerable side effects. The experiments in our studies are designed to identify new treatments to help Veteran’s at risk from problems related to lung scarring.